Translational Cancer Biology (TCB) T32 Training Program

Abstract
The problem of cancer in the 21st century remains a national priority, and as such, offers a
substantive long-term career opportunity for pre-doctoral and post-doctoral training. The
Translational Cancer Biology (TCB) T32 training program seeks support for 2 pre-doctoral and 4
post-doctoral trainees for 2 years each and emphasizes bench to bedside research
encompassing state-of-the-art areas of cancer research. Along with training in the fundamentals
of cancer research, trainees are provided with individualized access to many areas of basic and
clinical cancer research along with training in the responsible conduct of research (RCR),
including rigor in experimental design and data interpretation. Understanding how to work in
multidisciplinary teams and being familiar with “systems biology” and large data set analyses are
also a major goal of our training program. The TCB T32 program overarching goals are:
1. To train top-quality scientists capable of conducting independent cancer research.
2. To foster the intellectual, technical and communication skills required to succeed in the
academic or industrial arenas of today and in the future.
3. To provide an understanding of the basic, public health, and clinical problems of cancer.
4. To provide a training program that includes cancer related didactic and journal-oriented
courses as well as a program that includes biomedical ethics, RCR, enhanced
reproducibility, biostatistics, bioinformatics and data mining, analyses and sharing.
5. To provide training in grant writing, effective oral communications, and career planning.
6. To maintain a program-specific recruitment program attracting a geographical broad range
of applicants including underrepresented minority trainees.
7. To have regular retreats to provide specific T32 opportunities for trainees to present their
research and to develop the skills required to be effective scientists.
Our training grant eligible pre-doctoral and post-doctoral applicant pool has almost doubled during
the last 5 years. The ability of this training grant to bridge an existing outstanding foundation of
basic cancer research programs with our experimental therapeutics programs in the Harold
Simmons NCI Designated Comprehensive Cancer Center, distinguishes it from a standardized
general graduate and post-graduate educational program. We have 35 committed, well funded
faculty mentors, with a dedicated group of steering committee members, along with Cancer
Center administrative intellectual and financial support.

Public health relevance
This T32 application describes a comprehensive recruitment, training and retention program that combines a strong basic science curriculum with a strong translational cancer focus that distinguishes it from other training programs. Our goals are to train top-quality scientists capable of conducting independent cancer research; foster the intellectual, technical and communication skills required to succeed in the academic or industrial arenas of today and in the future; and to provide an understanding of the basic, public health, and clinical problems of human cancer. The Cancer Center Director of our NCI Designated Comprehensive Cancer Center provides substantial financial support for education and training.